Generating NTRK3-FlpO Mice for Genetically Intersecting A-beta Nociceptors

PROJECT SUMMARY
The dorsal root ganglion (DRG) contains diverse types of primary sensory afferents to mediate versatile
somatosensation, including pain. Nociceptive DRG neurons (nociceptors) can be divided into different types,
including C, Aδ, and Aβ nociceptors, based on their conduction velocities from slow to fast. Though multiple Cre
lines targeting mouse C and Aδ nociceptors have been generated, no genetic line is currently available for
specifically accessing and manipulating Aβ nociceptors, an important population of nociceptive afferents
particularly in humans. Intersectional genetic mapping is a powerful approach for interrogating molecularly
defined populations of neurons that can't be specifically manipulated using a single Cre line. Results from our
lab suggest the existence of an evolutionarily conserved Aβ nociceptors expressing NTRK3 and neuromedin B
(NMB) in both mice and humans. Interestingly, these neurons barely express PIEZO2, suggesting that they may
use a different molecular mechanism for sensing mechanical pain. The Luo lab has possessed a Nmb-Cre
mouse line, so we propose to generate and characterize a NTRK3-FlpO knockin mouse line in this R21
application. With this new mouse line, we can utilize an intersectional genetic strategy to specifically interrogate
mouse Aβ nociceptors for the first time. In Aim 1, we will generate new Ntrk3-FlpO founder mouse lines using
the Penn CRISPR/Cas9 Mouse Targeting Core Facility and characterize their recombination pattern by crossing
to Flp dependent reporter mouse lines. In aim 2, we will breed the Ntrk3-FlpO line with correct combination
patterns to Nmb-Cre and examine the intersectional recombination using Cre and Flp double dependent reporter
lines. We will quantify the number/percentage of the double positive DRG neurons, characterize co-expression
of known molecular markers of different types of mouse DRG neurons, examine their central and peripheral
projections, and determine their physiological properties. Taken together, we anticipate generating a new mouse
line, which would allow the field to genetically label and manipulate mouse Aβ nociceptors. This would pave a
new avenue to discover molecular mechanisms underlying mechanical nociception and determine functions of
Aβ nociceptors in chronic pain. This new Ntrk3-FlpO mouse line will also be an invaluable tool for other
investigators to study Aβ low-threshold mechanoreceptors, proprioceptors, or any other cell types expressing
Ntrk3.

Public health relevance
PROJECT NARRATIVE Nociceptors in the dorsal root ganglion are critical mediators for acute and chronic pain. This application proposes to generate a new mouse transgenic line that enable intersectional genetic label and manipulation of a population of fast-conducting Aβ nociceptors, which are evolutionarily conserved in mice and humans. The anticipated product would pave a new avenue to discover critical molecular and cellular mechanisms underlying chronic pain.